Impact of sex, flow, and glomerular permeability on endocytic uptake along the kidney proximal tubule

ABSTRACT/SUMMARY
Proteinuria occurs when the kidney proximal tubule (PT) is unable to fully reclaim albumin and other proteins that escape
the glomerular ﬁltration barrier. It is linked to increased risk and progression of chronic kidney disease (CKD). Proteinuria
is associated with higher risk for mortality and CKD progresses more rapidly in men compared to women. Understanding
how urinary excretion of albumin and other proteins changes with disease and is tied to PT function is critical to unravel
the link between proteinuria and CKD. This requires a greater understanding of where and how endocytic uptake is
regulated along the PT and how the PT responds to normal and pathologic variations in glomerular function. Filtered
proteins are internalized by the PT via receptor-mediated endocytosis facilitated by the multiligand receptors megalin and
cubilin which are diﬀerentially expressed along the functionally distinct S1, S2, and S3 subsegments that comprise the PT.
Uptake along the PT is modulated by receptor expression, cellular traﬃcking kinetics, tubule size, and the rate of ﬂuid
ﬁltration and reabsorption, all of which may vary signiﬁcantly between females and males and in kidney disease. For
example, female rodents appear to have lower single nephron GFR (SNGFR), smaller PT volume, and lower PT reabsorption
of Na+ and water. This project aims to investigate the determinants of PT endocytic capacity, focusing on how sex and
alterations in glomerular ﬁltration rate (GFR) and permeability impact PT endocytic uptake. The ﬁrst aim will develop a
multiscale model of protein uptake along the PT and characterize baseline sex-based diﬀerences in glomerular number,
volume and diameter of PT subsegments, and expression and subcellular distribution of megalin and cubilin in along the
PT. The second aim will assess how acute variations in ﬂuid shear stress aﬀect endocytic uptake in cell culture and in vivo.
The third aim will utilize an Alport syndrome mouse model to determine how increased protein ﬁltration impacts megalin
and cubilin expression and the urinary excretion of both albumin and low molecular weight protein cystatin C. By
integrating multiple quantitative imaging modalities in animals along with in vitro studies, this research will enhance our
ability to correlate the urinary excretion of proteins with PT and/or glomerular dysfunction and to predict disease
outcomes. The proposed research and training activities under the advisement of a mentorship team with diverse expertise
will provide Dr. Shipman with opportunities to develop an extensive quantitative imaging skillset, proﬁciency with mouse
kidney disease models, and strong collaborations throughout the renal physiology community. The collaborative
environment and resources at the University of Pittsburgh will provide critical support, networking, and training. The skills
developed along with the research ﬁndings resulting from this project will allow Dr. Shipman to secure their own NIH R01
funding to develop more comprehensive mathematical models of transport along the kidney nephron in normal and
disease states.

Public health relevance
PROJECT NARRATIVE Proteinuria occurs when the kidney proximal tubule is unable to fully reclaim albumin and other proteins that escape the glomerular ﬁltration barrier, and it is linked to increased risk and progression of chronic kidney disease. This project aims to develop a multiscale mathematical model of protein uptake along the length of the proximal tubule that includes the impact of baseline sex diﬀerences and variations in glomerular ﬁltration of ﬂuid and protein. Ultimately, this work will enhance our ability to predict kidney disease progression and response to potential therapeutics.